EVALUATION OF NONILLNESS MORTALITY ASSOCIATED WITH CHOLESTEROL REDUCTION

This study aims to determine if there is an association between serum cholesterol concentrations and anger, hostility, and/or depression in patients.